Auditory Processing of Complex Sounds

We propose to explore the role of the medial olivocochlear (MOC) efferent system in enhancing and
“sharpening” the encoding of complex sounds. We will use extracellular recordings in awake animals of inferior
colliculus (IC) and ventral nucleus of the trapezoid body, where MOC neurons are located. We also propose
psychophysical studies in humans, click-evoked otoacoustic-emission measurements, and a new
computational model that includes efferent pathways. In previous grant cycles, we discovered a novel neural-
coding strategy based on relatively slow fluctuations in the responses of auditory-nerve (AN) fibers, referred to
as neural fluctuations (NFs). For listeners with normal hearing, contrasts in NF profiles along the tonotopic axis
provide a robust code for spectral peaks and valleys across a wide range of sound levels and frequencies, as
well as in noise, but NF contrasts are adversely affected by sensorineural hearing loss. NF contrasts are
shaped by peripheral tuning and nonlinearities, which are in turn strongly affected by cochlear gain, motivating
our focus on the MOC system in this application. The MOC has traditionally been described as the hub of a
short reflex loop, with wide-dynamic-range inputs from the cochlear nucleus and an output that projects directly
to cochlear outer hair cells to modulate cochlear gain. An assumed role of the efferent system is to increase
the dynamic range of neurons, reducing rate saturation. It has not been possible to test this assumption using
AN recordings, but cochlear nucleus recordings in unanesthetized animals reveal that responses are saturated
at moderate levels and dynamic ranges are not increased, bringing into question this presumed function of the
efferent system. We propose a new concept: a purpose of the efferent system is to maintain and
enhance, or sharpen, NF contrasts. A less-studied but major input to the MOC descends from the IC.
Because nearly all IC neurons are sensitive to slow fluctuations on their inputs, NF contrasts are represented
by the profile of rates across the population of IC neurons. We hypothesize that IC input to the MOC
provides the NF-driven signal that is required by a control system that maintains and enhances NF
contrasts. The IC-rate profile, combined with the wide-dynamic-range input from the cochlear nucleus,
provides the efferent system with the information required to control NF contrasts across a wide range of
acoustic conditions. Exciting preliminary results support the hypothesis that this system actively sharpens the
representation of complex sounds. Our new computational model that includes efferent pathways provides
testable predictions for IC and MOC physiological responses and for psychophysical performance in human
listeners, with varying degrees of sensorineural hearing loss. Understanding nonintuitive effects of different
degrees of sensorineural hearing loss on NF profiles, in the context of dynamic MOC feedback, provides new
insight into the perceptual consequences of sensorineural hearing loss, and points towards novel strategies to
aid these listeners.

Public health relevance
The public-health significance of the proposed work is an advance in our understanding of the efferent half of the auditory system, or the neurons that carry signals from the brain back to the inner ear. We will use physiological, psychophysical, emissions, and computational modeling strategies to test our hypothesis that the subcortical efferent system “sharpens” or clarifies the perceptions of complex sounds, such as speech. We will also test the impact of sensorineural hearing loss on the function of the efferent system. This work will lead to novel approaches to dynamically control amplification in assistive devices such as hearing aids.